LNCRNA REGULATION OF GENE EXPRESSION & BEHAVIOR

PROJECT SUMMARY
Alcohol use disorder (AUD) is a major socioeconomic problem in the modern world. Acute and chronic alcohol
exposure is known to lead to system-wide changes in gene expression throughout multiple brain-regions and
cell-types. The mammalian genome is comprised of both protein-coding and non-protein-coding transcripts,
with less than 2% being protein-coding. Despite outnumbering protein-coding genes, the biological function of
most non-coding transcripts remains largely unknown. The largest class of non-coding transcripts are long
non-coding RNAs (lncRNAs), which are operationally defined as transcripts longer than 200 nucleotides in
length that do not encode for proteins. Most studies conducted to-date for lncRNAs have shown a critical role
of lncRNAs in regulation of gene expression. Additionally, lncRNAs are important for alternative splicing of
protein-coding transcripts, a biological process necessary for achieving cellular and molecular diversity of
proteins. Alternative splicing is crucial for mounting context-dependent responses of the immune system.
Chronic alcohol exposure has been previously shown to activate the neuroimmune system, altering CNS
plasticity and behavior. Astrocytes are a specialized glial cell-type, outnumbering neurons, and other glial cells
in the central nervous system (CNS). Astrocytes contiguously tile the entire CNS, playing a key role in
numerous biological functions including responding to CNS insults, activation of neuroimmune pathways, and
modulating behavior. Astrocytes are known to be involved in ethanol sensitivity and consumption; however, the
contribution of lncRNAs to regulation of neuroimmune pathways in astrocytes and ethanol-related behaviors is
unknown. This research proposal will test the overall hypothesis that the expression of lncRNAs in astrocytes
is important for coordinating ethanol-induced neuroimmune activation, alternative splicing, and ethanol-related
behaviors. Using a combination of in vitro and in vivo approaches this proposal will use advanced genomic
approaches to determine the causal relationship of lncRNAs in mediating astrocyte activation and ethanol-
related behaviors. Overall, our studies will establish novel molecular mechanisms for regulating gene
expression in response to excessive alcohol exposure and contribute to a better understanding of the
pathogenesis of AUD.

Public health relevance
PROJECT NARRATIVE The proposed project seeks to understand the cell-type specific role of lncRNAs in the regulation of neuroimmune-related gene expression and behavior(s) for excessive ethanol exposure. We will use cutting- edge approaches such gene mutagenesis (i.e., CRISPR) and high-throughput sequencing to determine novel molecular mechanisms associated with the development of Alcohol Use Disorder (AUD).